Functional Roles of NKp46 in Transplantation

DESCRIPTION (provided by applicant): Natural killer (NK) cells are effector cells of the innate immune system that can lyse target cells without prior sensitization, and have an important role in host defense to pathogens and transformed cells. NK cell function is controlled by a balance of negative and positive signals transmitted via germ-line encoded inhibitory and activating receptors. Although the concept of missing-self would suggest NK cells could target foreign allografts, the prevailing dogma has been that NK cells are not active participants in the mechanisms that culminate in graft rejection. Recent studies, however, challenge this conclusion and instead implicate NK cells in both acute and chronic allograft rejection. Quite paradoxically, NK cells have also been shown to facilitate tolerance to an allograft. To reconcile these disparate observations we hypothesized that NK cells, through expression and function of activating receptors, regulate other cells of the immune system especially dendritic cells (DC). Indeed we have demonstrated that DC- mediated activation of NK cells is dependent upon signaling through the NKp46 activation receptor. The goal of this exploratory/developmental proposal is to determine how NK interactions regulate the adaptive immune response after transplantation. We propose two integrated Specific Aims: 1) determine the phenotypic and functional features of NK cells after transplantation and 2) determine how NKp46 contributes to the function of NK cells post-transplant, to test our hypothesis that NKp46 is important in regulating NK-mediated immune functions post-transplant. Our innovative study will have important implications in designing strategies to prevent graft rejection and promote tolerance to an allograft.

Public health relevance
PUBLIC HEALTH RELEVANCE: Natural killer (NK) cells are effector cells of the innate immune system that can lyse target cells without prior sensitization. Recent studies by our lab and others support that NK cells have a paradoxical role in transplantation with strong evidence supporting the role of NK cells in both graft rejection and graft tolerance. We propose to examine the functions of NK cells after transplantation with the goal of developing strategies to improve outcomes for recipients of solid organ allografts. __SpecificAimsTextDelimiter__ 2. Specific Aims Natural killer (NK) cells are granular lymphocytes that can lyse target cells without prior sensitization, and have an important role in host defense to pathogens and transformed cells. A balance of negative and positive signals transmitted via germ-line encoded inhibitory and activating receptors control NK cell function. Although NK cells are often present at the site of graft damage, NK cells were generally not thought to be active participants in the mechanisms that culminate in graft rejection. However, recent studies by our lab and others support that NK cells have a dichotomous role in transplantation with strong evidence supporting the role of NK cells in both graft rejection and graft tolerance. These paradoxical findings lead us to hypothesize that NK cells, through expression and function of activating receptors, regulate other cells of the immune system especially dendritic cells (DC). Indeed our recent studies have shown that DC-mediated activation of NK cells is dependent upon signaling through the NKp46 activation receptor. NKp46 is a member of the natural cytotoxicity receptor (NCR) family of activating receptors that have a major role in triggering NK cell cytolytic activity (1). These receptors are expressed almost exclusively by NK cells and include NKp30, NKp46, and NKp44. Recent studies, however, suggest that isoforms of the NCRs can inhibit NK cell effector functions. The NCR NKp46 has been shown to be involved in innate immune defense. NKp46-deficient mice show increased susceptibility to lethal influenza injection (2) and aberrant tumor immunosurveillance (3). Further we suggest that in addition to a critical role in innate immunity, NKp46 functions to modulate the adaptive response to alloantigens. The goal of this exploratory/developmental proposal is to determine how NK interactions, especially through NKp46, regulate the adaptive immune response after transplantation. We propose two integrated Specific Aims that will test our hypothesis that the activation receptor NKp46 is important in regulating NK- mediated immune functions post-transplant. Specific Aim 1: Determine the phenotypic and functional features of NK cells after transplantation. a) Determine the phenotypic differences in NK cells and NK ligand-expressing cells that characterize the tolerant or rejecting state after transplantation. b) Determine the functional differences in NK cell interactions with populations of DC that characterize the tolerant or rejecting state after transplantation. We propose that there are phenotypic and functional differences between the NK cells and populations of DC, in the periphery and graft and in the rejecting and stable state, post-transplantation. We will employ over- expression, and down-regulation strategies to examine the requirement for specific NK cell activation receptors in the cytotoxicity, activation, and maturation of populations of circulating and graft-associated DC. Specific Aim 2: Determine how NKp46 contributes to the function of NK cells post-transplant. a) Determine the involvement of NKp46 in the inhibitory, cytotoxic, and regulatory NK immunological synapse. b) Determine if there are functionally distinct isoforms of NKp46 expressed on NK cells after transplantation. The experiments proposed in this Aim will determine how activation receptors contribute to interactions with other cells and specifically if NKp46 is at the critical interface between an NK cell and a target cell during activation, regulation, and cytotoxicity. Further, sequence analyses of NKp46 from NK cells isolated from the graft and periphery will determine if there are functional isoforms of NKp46 that are associated with graft outcomes.